Regulation of Cardiac Collagen Content by SLIT3

PROJECT SUMMARY
Cardiac fibrosis is a common adverse myocardial remodeling event that worsens heart failure caused by chronic
ventricular pressure overload and other cardiac pathologies such as heart failure with preserved ejection fraction.
Due to our incomplete understanding of the pathogenesis of cardiac fibrosis, no specific antifibrotic therapy
exists, and affected patients are usually treated by heart transplantation, a therapy that has many limitations.
Motivated by this clinical problem, our research has recently uncovered new insights into the regulation of cardiac
collagen content and fibrosis, and, in this application, we propose to extend this work to gain further
understanding into cellular and molecular mechanisms. In our recent work, we discovered that global deficiency
of SLIT3, a secreted glycoprotein which binds to the ROBO receptors, leads to a marked decrease in cardiac
collagen content, improved diastolic function in adult mice, and decreased cardiac fibrosis and improved survival
after left ventricle (LV) pressure overload induced by transverse aortic constriction (TAC). We also found that
SLIT3 stimulates cardiac fibroblast function, intracellular signaling, and collagen production in vitro. Collectively,
these results support a developmental link between SLIT3 and collagen deposition during both normal cardiac
homeostasis and pathologic stress. However, as these studies relied on SLIT3 global knockout mice where
SLIT3 knockout potentially affected developmental programs, the more specific, postnatal functions of SLIT3 -
as well as the details of the cellular and molecular signaling - remain undefined in the adult state. New preliminary
data using SLIT3 floxed mice and inducible Cre promoters, we find that SLIT3, generated by either cardiac
pericytes or fibroblasts, regulates collagen expression in vitro and in vivo in the postnatal state, most likely, by
signaling through ROBO1. Based on these results, our overarching hypothesis is that cardiac pericyte and
fibroblast-mediated SLIT3 regulate fibroblast activation and function via ROBO1 during conditions of
homeostasis and pressure overload. As such, we propose the following aims: (1) Characterize the role of SLIT3
in regulating adult cardiac fibroblast function in vivo. (2) Determine the details of how SLIT3/ROBO1 regulates
adult cardiac fibroblast activation and function in vivo and in vitro. (3) Characterize the role of cardiac pericyte
and fibroblast-mediated SLIT3 on the ROBO1-dependent response of cardiac fibroblasts during LV pressure
overload in vivo. This research will reveal new cellular and molecular concepts of cardiac fibroblast regulation
and will further advance our understanding of the pathogenesis of cardiac fibrosis. The results of this research
may provide the rationale for targeting SLIT3-ROBO1 to mitigate pressure overload-induced cardiac fibrosis,
thereby benefiting patients with heart failure and other forms of cardiac disease.

Public health relevance
PROJECT NARRATIVE Cardiac fibrosis, or the accumulation collagen, occurs almost universally in all cardiac diseases and can contribute to the worsening of heart failure. There are no therapies for cardiac fibrosis. In this proposal, we will determine the role of SLIT3-ROBO1 signaling in cardiac collagen regulation as well as in the pathogenesis of cardiac fibrosis. Results of this study will increase our understanding of how cardiac fibrosis occurs and may identify novel targets for antifibrotic therapies.